Development of ubiquitin-specific protease 8 (USP8) inhibitors

Project Summary
Ubiquitin specific protease 8 (USP8) is a cysteine protease that can deubiquinate receptor tyrosine kinases. USP8
regulates endocytosis and through this activity modulates the degradation of diverse substrates by the autophagy-
lysosome system. In oncology, USP8 has been shown to deubiquinate and stabilize mutant epidermal growth
factor receptor (EGFR) in non-small cell lung cancer (NSCLC). Preliminary studies show that USP8 inhibition
promotes ubiquitin-mediated degradation of mutant EGFR in NSCLC cell lines and primary patient samples both
sensitive and resistant to EGFR kinase inhibition. These results suggest that UPS8 inhibition could provide a
therapeutic strategy for overcoming gefitinib-resistance in NSCLC. However, the USP8 inhibitor used in these
preliminary studies is an early generation inhibitor that lacks the requisite potency and selectivity of a high-quality
probe compound.
The goal of this research program is to develop the first reversible USP8 inhibitors with the requisite potency,
selectivity, and cell permeability to interrogate the potential of USP8 as a therapeutic target in NSCLC. The first
aim is to perform medicinal chemistry optimization of lead scaffolds identified from a high throughput screen. I
will design analogs of each compound to broadly survey regions of the molecule that are required for activity and
positions that can be modified to modulate properties such as solubility and stability. For these studies, one
position in the molecule will be modified at a time then productive changes will be combined. In the second aim,
these inhibitors will be characterized with respect to their cellular target engagement, anti-proliferative effects,
and effects on the stability of EGFR in mutant and wild type NSCLC cell lines. In the third aim, I will use the
newly developed USP8 inhibitors as probes in phenotypic, proteomic, and transcriptomic assays across a broad
set of cancer cell lines to uncover new USP8 biology in an unbiased manner. This proposal therefore outlines the
development of the first USP8 inhibitors with the required potency and selectivity to be used as cellular probes
to study USP8 biology, and contributes to evidence for USP8 inhibition as a therapeutic strategy for NSCLC.

Public health relevance
Project Narrative The deubiquinating enzyme, ubiquitin specific protease 8 (USP8), protects growth factor receptors including epidermal growth factor receptor (EGFR) from degradation. USP8 suppression, by either genetic silencing or pharmacological inhibition, promotes ubiquitin-mediated degradation of mutant EGFR in non-small cell lung cancer (NSCLC) lines and patient samples, and thus represents a promising strategy for overcoming gefitinib resistance in lung cancer. This proposal has important public health applications because it offers the first potent, selective, and cell permeable USP8 inhibitors, which will not only serve as useful tool compounds with which to study USP8 biology, but will also inform the design of future targeted therapies for NSCLC.